Identifying High-Risk Situations through Human Spatial Behavior and Cognitive developmental Cues and Triggers in Relapse Prevention

PROJECT SUMMARY/ABSTRACT Project Summary: Cognitive behavioral treatments have been found to facilitate knowledge and behavior patterns that help guide individual action in adaptive ways. cognitive-based assists among Previous research shows that visual representation strategy for counseling improves treatment engagement and clients with healthy decision making and aids in reducing cognitive and social deficits common drug users in treatment.To further investigate the social and ecological impacts on treatment engagement and relapse, the proposed supplement seeks to employ a cognitive mapping framework to explore the development and acquisition of spatial behavior and how these behaviors interact with relapse and treatment engagement outcomes. Using a multi-sensory research approach and phenomenological qualitative research design, we will recruit 30 participants enrolled in the parent study and a sub-sample (15 participants) will complete a follow-up interview 90-days after the initial interview. Semi-structured interviews will be used to capture human spatial behavioral patterns in relapse treatment. The proposed supplement will further aid in the development of the trainee's behavioral intervention skills with focus on examining how people produce and experience space in relapse prevention treatment. The following overarching training objectives include training in (1) cognitive behavioral intervention development, (2) GIS and activity space skills, and (3) Mhealth cognitive behavioral treatment approaches to relapse prevention. Project Aims: Aim 1: Examine the interactions between human spatial behavior and social, cultural factors within the context of relapse prevention. a. Geographic and participant visual illustrations of 30 participant interactions within their physical and social environment will be mapped during in-depth interviews and thematically analyzed to assess social and psycho-geographic notions of place, social relationships, and cognitive pro-cesses in relapse prevention. Aim 2: Examine the developmental processes of human spatial behavior across stages of treatment. a. Following a sub-set of 15 participants, visual illustrations mapped during in-depth interviews will be assessed twice within a 90-day window of the initial assessment. The follow-up interview will assess variations and changes in social and psycho-geographic notions of place, social relationships, and cognitive pro-cesses across developmental stages of relapse prevention. Aim 3: Explore the acceptability of cognitive mapping behavioral approaches to relapse prevention including possible ways to integrate in technology.

Public health relevance
Project Narrative, LaDrea Ingram, EdD, CHES Project Narrative The proposed supplement seeks to examine the impact of human spatial activities on the foundation of relapse behavioral processes and treatment outcomes. The proposed supplement will further aid in the development of Dr. Ingram's behavioral intervention skills with focus on examining how people produce and experience space in relapse prevention treatment. The following overarching training objectives include training in (1) cognitive behavioral intervention development, (2) GIS and activity space skills, and (3) Mhealth cognitive behavioral treatmentapproaches to relapse prevention.